TRAINING IN CANCER BIOLOGY

Now in its tenth year, this is a post-doctoral research training program that is targeted to Ph.D., M.D. and M.D./Ph.D. scientists. The training program centers in the Department of Pathology at Washington University and includes 15 faculty members, mostly of the Departments of Pathology and Internal Medicine. The applicants are M.D.'s training in clinical programs in Pathology who then undertake a serious full-time research training; or fellows that apply directly to the faculty. (The distribution is about the same for both groups.) The training period is for 2 to 3 years. (Of 25 graduates from our program 88% continue research careers and 60% are already in university faculty.) The faculty is constituted by a highly interactive group made up of immunobiologists and molecular cell biologists. Most of the laboratories are closely located at Washington University School of Medicine. The faculty includes ten Professors (Unanue, Korsmeyer, Allen, Baenziger, Ley, Milbrandt, Ratner, Schreiber, Schwartz and Stahl), three Associate Professors (Lieber, Murphy and Speck) and two Assistant Professors (Dowdy and Shaw). All the faculty has research support (12 from Cancer programs). The training includes the two to three years of laboratory experience, attendance to seminars, frequent presentations of research projects, and attendance to a Cancer Biology course. The faculty does research in basic cell and molecular biology with emphasis on immunobiology and cell growth and differentiation. Trainees are exposed to the latest approach in molecular biological approaches (including transgenic and gene ablation approaches), peptide chemistry and cell handing and culture. The teaching environment is strong without barriers for trainees to learn from more than one faculty member. Applicants are selected by a Steering Committee of 5 faculty members. The Committee is also responsible for their evaluation and their progress.